Task B1: Phase 1 Clinical Trial: Carbapenem-resistant Enterbacterales (CRE) Infections

The Phase I Clinical Trial Units provide a vehicle for the investigation of new therapeutic and immunomodulatory agents for the treatment of infectious disease, including biodefense pathogens.